Conference Scholarships for APHA's 2023, 2024, & 2025 Annual Meetings to Support Underrepresented Students in Environmental Health

Project Summary/Abstract
The American Public Health Association (APHA) is a large organization with over 25,000
members. APHA holds annual meetings to convene 1000s of new and longtime public health
leaders working towards health equity. The 151st Annual Meeting will be held from November
12-15, 2023 in Atlanta, GA. The theme for this year’s conference, with an anticipated
attendance of over 12,000 in total, is “Creating the Healthiest Nation: Overcoming Social and
Ethical Challenges.” With future themes to be determined, the 152nd Annual Meeting will be
held in Minneapolis, MN, and the 153rd Annual Meeting will be held in Washington, D.C.
Sections are the primary professional units of the APHA, and they conduct activities that
promote the mission and fulfill the goals of APHA. Specifically, the Environment Section’s goal
for upcoming meetings is to foster interest in environmental health and justice, increase student
involvement, and provide offerings on various environmental health and justice topics. The
Section offers a wide variety of 30+ sessions, posters, plenary sessions, and special events to a
diverse audience representing academics, health professionals, community members, and
students. We aim to leverage a network of members, including over 1,600 academic,
governmental, and community-based environmental health professionals to promote our
conference scholarship to a wide range of U.S. schools.
Our aims for the R13 grant are to:
1) Build and support the next generation of environmental health leaders with support for
underrepresented students to attend, engage, enhance, and thrive at the meeting;
2) Foster mentorship between students and public health professionals in research, practice,
and advocacy, particularly around environmental health science and justice topics;
3) Connect students to a forum for sharing lessons from research and practice to activate policy
and programmatic changes needed to improve environmental health equity; and
4) Engage scholarship recipients beyond the annual meeting through Section leadership roles,
networking opportunities, and intergenerational mentorship, as interested.
All of this is done in alignment with NIEHS’s strategic plan and mission to conduct and support
the very best environmental health sciences in the context of real-world public health needs.
Ultimately, we aim to create a professional pathway within APHA for underrepresented students
geared towards environmental health careers, while providing mid- and longtime members the
opportunity to learn from the next generation of environmental health scientists.

Public health relevance
Project Narrative The program for the Environment Section at the 2023, 2024, and 2025 American Public Health Association Annual Meeting and Expos will benefit students. In particular, we aim to support underrepresented students defined as those coming from underserved populations, underrepresented institutions, or communities underrepresented in the field of environmental health in terms of economic, racial/ethnic, or other demographic characteristics. This funding would allow scholarship recipients the opportunity to discover the latest science, policy and practice in the field of environmental health; learn about efforts to address the health impacts of environmental exposures; network with leaders and peers in the field; and present their own work in environmental health.